NEUROTRANSMITTER RECEPTOR PURIFICATION AND STRUCTURE

Neurotransmitter receptors; adrenergic (beta1, beta2, alpha1, and alpha2), cholinergic (muscarinic and nicotinic), and benzodiazepine receptors are being isolated and purified in order to understand the molecular basis of receptor function and neuronal communication. Specific projects are underway to provide precise structural information on each of the above receptor proteins. Structural data being obtained include primary sequence data, proteolytic digest maps, topology information and structure-function data, e.g., neurotransmitter binding site localization, sugar localization, membrane domain and effector coupling protein recognition domains. Our data have demonstrated that structural similarities exist among non- pharmacologically related neurotransmitter receptors (muscarinic, cholinergic and alpha adrenergic) and that these neurotransmitter receptors mediate cellular modulation via protein conformational changes initiated by neurotransmitter binding to the binding site in their transmembrane domains. Receptor coupling is mediated by the intracellular loops of the receptors which appears to be the effector protein (GTP- regulatory protein) recognition portion of the receptor. Electron microscopy and high performance size-exclusion chromatography of purified receptors indicate that the alpha2 and beta2 receptors exist as homodimers while the muscarinic receptor is monomeric. Protein preparative procedures have been established which include various HPLC steps, ligand affinity chromatography, monoclonal antibody affinity chromatography, preparative SDS- gel electrophoresis, lectin afinity chromatgraphy, ion exchange purification protocols is now permitting simultaneous detailed structural comparisons of all adrenergic and cholinergic receptor proteins as well as proteins expressed from cloned receptor genes. *(Transferred from LNP on 7/87).